New Directions in Sustainable Open-Shell Radical C-C Bond Formations Enabled by Merging Modern Computational and Experimental Methods

Project Summary/Abstract
Transformations that proceed via carbon-centered radicals are amongst the most versatile and powerful
reactions in the synthesis of medicinally relevant molecules and complex natural products. However, despite
recent surge in the discovery of sustainable open-shell catalytic methods that enable C-C bond formations, our
knowledge of the molecular-level interactions controlling the rate- and selectivity-determining steps is these
transformations is rudimentary. In last grant cycle, we built a team of computational and experimental chemists
that used a mechanistic-driven approach to advance the understanding of open-shell transformations and inform
catalyst and reaction design. In the next five years, we will continue to combine state-of-the-art computational
methods, organic synthesis, and, new to this cycle, advanced inorganic spectroscopic tools to develop predictive
models of reactivity and selectivity of open-shell first-row, transition metal-catalyzed radical cross-couplings
(RCCRs). As in the past, this information will be used to guide the development of highly efficient and chemo-,
regio-, and stereoselective RCCRs that can be utilized in academic and industry settings for the preparation of
bioactive compounds.
One aspect of the proposed work involves continuing to develop sustainable methods that enable
selective dicarbofunctionalization of alkenes. In particular, we will explore ligand- and ligand-free iron catalytic
systems with structurally and electronically diverse alkyl radical precursors, nucleophiles, and olefin coupling
partners to enable selective multicomponent carbon-carbon bond formations. High-level quantum mechanical
calculations in combination with organic synthesis and in situ spectroscopic methods will be utilized to elucidate
the mechanisms and, in particular, the impact of spin, oxidation state, and speciation of iron species in promoting
or suppressing reaction channels that control alkyl radical formation, relay, and C-C bond formation. Another
aspect of this proposed work involves continuing and expanding collaborative efforts to (i) elevate the
understanding of open-shell, first row-transition metal-catalyzed radical two- and multicomponent component
cross-couplings and (ii) develop predictive models of reactivity and selectivity. These reactions proceed through
carbon-centered radical intermediates, open-shell organometallic species, and/or photoexicited electronic states
which pose practical problems to identify and quantify the factors controlling the lifetimes, dynamics, and
reactivity of these species. As in the past, through tight-knit collaborations with synthetic organic and inorganic
experts, we will use high-level quantum mechanical calculations (including multireference and molecular
dynamic simulations), rigorously calibrated against experimental data, to interrogate the mechanisms and to
guide the development of new catalysts and reagents for currently sluggish or unselective reactions. Our long-
term goal is to elevate the understanding and development of open-shell, first-row transition-metal catalyzed
cross-couplings to the level of closed-shell palladium-based systems in organic synthesis.

Public health relevance
Project Narrative In this proposal will use modern theoretical tools and experiments to improve our knowledge of the factors controlling reactivity and selectivity in open-shell catalytic transformations and, in turn, accelerate the development of new sustainable catalytic reactions. Through detailed mechanistic studies, we will provide catalyst, substrate, and reagent design principles. New reagents, catalysts, and chemical reactions are expected to provide rapid access to untapped chemical space and synthesis of compounds with desirable properties for applications to human health.